Leveraging novel pediatric SHIVs to identify biomarkers of prophylactic efficacy of bnAb against breast milk HIV transmission

Abstract
Pediatric HIV continues to be an important public health concern in resource-limited areas. While antiretroviral
therapy (ART) to pregnant and breastfeeding women has significantly reduced the rate of vertical transmission,
in 2022, 130,000 new pediatric HIV infections occurred. Strategies that can complement ART, such as
immune-based interventions, are critically needed to achieve the goal of a generation free of HIV. Animal
studies and recent clinical trials have demonstrated the potential for passive immunization with broadly
neutralizing antibodies (bnAbs) in HIV prevention. This strategy is especially suitable when transmission risk is
well-defined in time such as during breast milk transmission, which accounts for almost 50% of pediatric
infections. To advance the clinical development of this promising strategy, it is critical to define biomarkers of
efficacy that can be used as a surrogate of protection in clinical trials to predict its efficacy. The predicted
serum neutralization 80% inhibitory dilution titer (PT80) is a recently developed biomarker that integrates the
IC80 and the serum concentration of the administered bnAb. In the adult AMP clinical trials, which evaluated
the efficacy of the bnAb VRC01 for the prevention of sexual transmission of HIV in heterosexual women and in
men who have sex with men, PT80 was strongly associated with the level of prevention efficacy. Moreover,
PT80 has been associated with efficacy of single bnAb passive immunization in non-human primate models of
sexual transmission. Yet, PT80 has not been validated in the setting of oral transmission or to date there is no
biomarkers that predict the preventive efficacy of combination bnAbs. Using an infant non-human primate
model of breast milk transmission, this project will test the hypothesis that PT80 or another biomarker can
predict the efficacy of combination bnAb passive immunization for the prevention of breast milk HIV
transmission. The specific aims are: 1) Engineer and characterize SHIVs expressing the Env of breast
transmitted founder viruses; 2) Evaluate the ability of PT80 to predict the efficacy of passive immunization with
a single bnAb in the setting of repeated oral breast milk TF SHIV exposure; and 3) Identify correlates of
protection in the setting of combination bnAb and oral exposure to a virus swarm. By defining a biomarker that
predicts the efficacy of bnAbs against breastmilk HIV acquisition, this study will provide novel insights for the
design of clinical trials evaluating bnAb immunotherapy for the prevention of postnatal HIV acquisition; notably
by 1) allowing for informed selection of bnAbs and combination bnAbs for clinical evaluation; 2) allowing for
rationale design of an efficacy trial of a combination bnAb regimen to prevent breastmilk acquisition in infants,
with the goal of licensure, and 3) ultimately, allowing cost saving 'surrogate endpoint' trials of bnAbs/combo
bnAbs, as support for regulatory approval.

Public health relevance
Public health statement. Breast milk transmission of HIV continues to be an important public health concern in limited resource areas and there is a critical need for novel preventive strategies that can complement maternal antiretroviral therapy. Passive immunization with broadly neutralizing antibodies (bnAb) has shown protection in animal models and good safety profile in clinical trials. This study aims at identifying a biological surrogate maker of bnAb preventive efficacy to help advance the clinical development of this promising strategy for the prevention of breast milk HIV transmission.